Modeling the contribution of coronavirus cellular tropism to viral pathogenesis

Summary
The cell and tissue tropism of viruses is defined as the capacity of a virus to infect
specific cells and tissues and is determined by both viral and cellular factors. An
important factor for initiation of infection is cell entry, which is dependent on the ability of
the virus to dock with its cognitive receptor. A growing understanding of species
differences in ACE2 structure and, perhaps more importantly, in tissue specific patterns
of expression has underscored the potential limitations in the use of mouse models for
the study of disease pathogenesis of coronaviruses such as SARS-CoV-2 that rely on
ACE2 for cellular entry. We propose to implement a strategy for the rapid generation of
mouse models in which human ACE2 expression is limited to individual or multiple
airway epithelial populations. Using these lines, we will examine the impact of the
cellular pattern of ACE2 expression in the respiratory tract on the sequence of events
following exposure to SARS-CoV2 coronavirus.

Public health relevance
Narrative This proposal addresses a gap in our knowledge regarding the impact of cellular tropism of coronavirus such as SARS-CoV-2 on disease pathogenesis. We propose the generation of unique models in which infection of respiratory epithelia cells by virus is limited to specific cell populations, thus providing information regarding their contribution to COVID-19 like lung disease.